Racial disparities in breast cancer risk and gene expression-roles of genetics and lifestyle factors

PROJECT SUMMARY
African American (AA) women have 40% higher breast cancer mortality and are more likely to be
diagnosed with aggressive subtypes, such as triple negative breast cancer, than European
American (EA) women. Exact reasons for these disparities remain unclear – but genetics and
lifestyle may both play a role. However, it is unclear how genetic and lifestyle factors contribute to
racial differences in molecular profiles of breast cancer. Our recent collaboration with Zambian
cancer researchers presents a unique opportunity to include African Zambian (AZ) breast cancer
patients in research to help reveal the underlying mechanisms for breast cancer racial disparity.
Given the drastic differences in lifestyle and environmental exposures, yet relatively small genetic
differences between AA and AZ, including AZ, AA, and EA breast cancer patients in one study will
offer an excellent opportunity to disentangle the contribution of genetic predispositions from
lifestyle exposures on the molecular profiles and tumor characteristics of breast cancer. We
propose to recruit 250 incident AZ breast cancer patients, collect clinical and lifestyle data, obtain
tumor tissues, and performing RNA sequencing (RNA-Seq). These data will be compared with
existing data from the Southern Community Cohort Study. Specially, our study has the following
aims: 1) to recruit 250 African Zambian women with pathologically confirmed breast cancer at the
Cancer Disease Hospital in Lusaka, Zambia; 2) to derive molecular profiles of breast cancer in
AZ women and compare with those from AA and EA women. We will perform RNA-Seq on breast
tumor tissue samples from AZ patients to derive gene expression levels, molecular intrinsic
subtypes of breast cancer, and PAM50-based risk of recurrence scores (ROR-S). The
demographic, clinical, and molecular data will be summarized and compared across these three
racial/ethnic groups. Expression levels of known breast cancer susceptibility genes, molecular
intrinsic subtypes, and ROR-S derived in Aim 2 will be utilized to distinguish the differential effects
of genetic ancestry versus lifestyle on breast cancer molecular phenotype among the three
racial/ethnic groups. This will be the first epidemiological study to compare molecular profiles of
breast cancer across AZ, AA, and EA women, shedding light on the underlying genetic and
lifestyle factors that contribute to racial disparities in molecular profiles of breast cancer. This study
will generate important preliminary data informing a full-scale investigation to delineate variances
in genetic predispositions and lifestyle factors in association with breast cancer risk. This will also
be the first molecular epidemiology study of breast cancer in Zambia, laying the foundation for
conducting etiological research on breast cancer in the country.

Public health relevance
Narrative Black women are more likely to have aggressive types of breast cancers and a high mortality than White women. We propose to compare risk factors and tumor genomics of Black breast cancer patients from Zambia and the United States, as well as White women from the United States to gain insight of the underlying mechanisms of breast cancer disparity.